An ultra-high (FLASH) dose rate x-ray cabinet system for pre-clinical laboratory radiation research

PROJECT SUMMARY/ABSTRACT
Flash radiotherapy, the delivery of high radiation dose (10 – 30 Gy) at ultra-high dose rates (40 – 200
Gy/s), has recently been shown to reduce significantly normal tissue toxicity compared to conventional
irradiation, while maintaining tumor control probability at similar level. Great excitement has since ensued
about the transformative potential of FLASH radiotherapy. However, the biological mechanisms of FLASH
irradiation (FLASH effect) are not well understood. The clinical translation of FLASH irradiation
necessitates comprehensive laboratory studies to elucidate the biological effects as well as pertinent
technological and physical requirements. At present, FLASH research employs complex accelerator
technologies of limited accessibilities. We propose to develop a novel self-shielded x-ray irradiation cabinet
system, as an enabling technology to greatly enhance the preclinical research capabilities of the radiation
research community. The system employs two commercially available high capacity 150 kV fluoroscopy
x-ray sources with rotating anode technology in a parallel-opposed arrangement. For a medium less than
2 cm in thickness, the system can deliver both FLASH and conventional dose-rate radiations to support a
broad range of laboratory radiation research. We submit our proposal as an academic-industrial
partnership (AIP) to design and construct the first FLASH kilo-voltage x-ray cabinet system for preclinical
laboratory research. The AIP consists of Johns Hopkins University (JHU) with the expertise in radiation
physics, dosimetry, Monte Carlo simulation, robotics, and preclinical radiation research, Xstrahl to
manufacture and commercialize the FLASH cabinet system for preclinical research, and University of
Pennsylvania (UPenn) to support in-field validation of the novel system. A JHU patent application is
currently under review. Our specific aim for the 4-year research efforts are: (1) Design a new self-shielded
pre-clinical radiation research system based on in-depth characterization of the dosimetric properties of
the x-ray beam for both FLASH and conventional radiations, and the mechanical requirements of the
system to support small and large radiation fields. (2) Develop a Monte-Carlo based dose calculation
system to provide information on the delivered dose, dose rate, and LET distributions in the irradiated
target, pertinent to FLASH research. (3) Conduct in-field validation, at JHU and UPenn, of the system
dosimetric performance, and demonstrate the system capability for FLASH and conventional irradiation of
in-vivo models. The successful development of the system by the AIP will make available transformative
FLASH capabilities for the laboratory researchers, and significantly enhance mechanistic and translational
research on FLASH irradiation.

Public health relevance
PROJECT NARRATIVE We propose to develop a self-shield kilovoltage x-ray cabinet system with the capabilities of delivering both FLASH and conventional dose-rate irradiations for pre-clinical laboratory research. The novel system, unlike other technologies, make FLASH irradiation broadly available to the research community, which is critical to advance the research and translation of FLASH radiotherapy. FLASH has transformative potential to enhance significantly the efficacy of radiotherapy in cancer treatment.